The Annual Food Safety and Defense Conference, held in the District of Columbia, is an educational conference and collaborative effort with stakeholders in the District.

2201 Shannon Place SE
Washington, DC 20020
Phone: (202)738-7013 Fax: (202) 535-1359
Email: [email] Website http: www.doh.dc.gov
April 12,2024 June 30,2024
Coming out of a pandemic we hope to have the annual conference in person in addition to an on-line
virtual conference

Public health relevance
Attachment 1 Project Narrative Introduction th Regulation Licensing Administration (HRLA), Food Safety and Hygiene Inspection Services Division (FSHISD) seeks funding of $25,000 from the United States Food and Drug Administration, as part of the Food Protection Task Force (FPTF) and Integrated Project Grant Program (R19)